NAPC Learning Management System Supplemental Funding

The proposed NAPC will leverage a multi-year history of productive collaboration between two primary
institutions, the University of Pittsburgh (Pitt) and the University of Iowa (Iowa), to employ an enhanced “team
science” approach to address the community engagement, training, and education needs of the NNLM All of Us
Program. The NAPC serves a critical role in coordinating engagement, programs, partnerships, activities, and
training offered by NNLM in support of the NIH All of Us Research Program. NAPC will develop and distribute a
robust portfolio of community-based programs and services, create opportunities for national and regional
engagement, and build relationships within NNLM and the All of Us Ecosystem. In doing so NAPC ensures that
NNLM members can build capacity to improve health, digital, and research literacy in their communities, and
that individuals, particularly populations underrepresented in biomedical research (UBR), will have access to the
knowledge, resources, and skills necessary to understand precision medicine and participate in All of Us.
As previous NNLM All of Us pilot program awardees, Pitt and Iowa bring a unique understanding of the
complexity of the program, quality and experienced personnel, and existing professional relationships with
NNLM, the All of Us Ecosystem, public libraries, and community organizations. Together, these two institutions
will create a dynamic and collaborative research environment, provide high-quality innovative program
deliverables, and implement innovative workflows, mechanisms, and initiatives to grow the NNLM All of Us
Program. The NAPC will continue to build on the work of the NNLM All of Us pilot by using data-informed
methods and tools to identify new opportunities to reach diverse communities and organizations with little
previous engagement. We will increase capacity, programming, and engagement opportunities around health,
digital, and research literacy. We will continue to assess and support the training and education needs of the All
of Us consortium and advance the science of engagement, community-based participatory research, and
human-centered design through training, publications, presentations, and other modes of dissemination so that
others can incorporate NAPC best practices into their training and community engagement programs.
The NAPC has three overarching aims to accomplish the goals of the NNLM All of Us Program:
(1) Increase All of Us learning options for a wide variety of audiences in cooperation with community partners,
NNLM, the All of Us Consortium Training Board, and the All of Us Ecosystem. Supplemental funding will support
this aim through: (A) migration of TEP from Moodle LMS to Absorb LMS, to enhance user experience and
learning management system functionality, and (B) Advanced access for an increased user base, as outlined by
All of Us. (2) Raise awareness of and interest in All of Us; (3) Build capacity to improve the public’s knowledge,
resources, and skills to make informed decisions about health, contribute to research, and engage with digital
health information and research.

Public health relevance
The Network of the National Library of Medicine (NNLM) All of Us Program Center (NAPC) proposes to expand capacity of the center and the All of Us Training and education Platform (TEP) to support identified needs for enhancing user experience and functionality of the TEP Learning Management System (LMS), and to support identified needs for researcher training. The recommended actions will support the development of new researcher training to increase opportunities for training engagement with researchers, modular training development to enhance learning, and robust data collection and reporting on training engagement and learning outcomes across All of Us Research Program audiences.